The Role of MDM2 in FMRP regulation of neuronal development

Abstract:
Abstract is found in Research Plan.

Public health relevance
Project Narrative: This is not required for this administrative supplement.